A user-customizable personalized normative feedback intervention for alcohol harm reduction in young adults: Feasibility, acceptability, and preliminary efficacy.

The proposed project entails (1) user-centered development of an innovative web-based intervention to reduce
alcohol-related harm among young adults, and (2) pilot testing the intervention to assess indices of acceptability
and engagement, as well as preliminary assessment of efficacy, relative to a treatment-as-usual and attention-
matched control conditions. Personalized normative feedback (PNF) – i.e., correcting misperceptions about
peers’ alcohol use behaviors and contrasting one’s own use to the actual norms of their peers – is an economic
strategy that is widely used on college campuses. Although effects of PNF interventions are consistent, and
generally maintained, the effect sizes can be improved; thus, innovation is needed to further move the needle.
The proposed intervention will expand traditional PNFs that generally only provide normative feedback for ‘typical
students’ at participants’ university, by providing options for users to customize their experience and explore a
variety of more specific normative feedback modules; for example, providing normative feedback specific to first
year students, Hispanic students, or sexual minoritized students (many other modules will be available). This
novel paradigm will provide users with a truly personalized and engaging experience in which individuals receive
normative feedback on the referent groups that are most meaningful and interesting to them. Although this
customizability is anticipated to increase engagement and efficacy, it will also provide more equitable prevention,
as many students may not identify with the ‘typical student’ (e.g., minoritized students) and these students may
be more receptive to feedback that is more aligned with their own identities. Thus, this pilot project will lay the
groundwork for a novel customizable personalized normative feedback (CPNF) intervention paradigm whereby
users can choose to explore normative feedback for a wider variety of referent groups (as many as they wish to
explore), in addition to typical student norms feedback. In Phase 1 of the pilot project, we will develop and refine
the CPNF intervention content, design, and deliverability through a multi-step, iterative process called rapid
prototyping (N=30). In line with user centered design, young adults will be incorporated into and provide feedback
on all steps to ensure that a relevant and engaging final product is created. Rapid prototyping allows us to quickly
gather user feedback and make changes based on user preferences. Once the intervention is developed and
fully programmed, Phase 2 will entail a pilot RCT (N=250) of the CPNF intervention. Aim 2 will specifically
examine feasibility of the CPNF intervention paradigm in terms of acceptability, engagement, interest, and
satisfaction, and will examine whether these indices are higher among students who are in most need of this
type of intervention (e.g., heavier drinkers). Aim 3 will entail a ‘proof-of-concept’ test of efficacy, relative to
standard PNF and attention-matched control conditions, in terms of reductions in alcohol use and negative
consequences assessed at 1- and 3-month follow-ups, and test whether CPNF increases treatment equity for
students of marginalized identities (race/ethnicity and sexual/gender minorities), relative to standard PNF.

Public health relevance
To reduce harm related to high-risk alcohol use and negative consequences among young adults, researchers and preventionists have targeted normative misperceptions regarding the drinking behaviors of other young adults (i.e., norm-correcting interventions). The proposed project will develop and pilot test an innovative paradigm for leveraging social norms within brief interventions that entails user customization of which (and how many) normative referent groups they receive feedback for (e.g., drinking norms for sexual minoritized peers) so that the content is meaningful and engaging to all users, including historically marginalized groups. With proof-of-concept support that this novel intervention paradigm is feasible (i.e., acceptability, engagement, interest), efficacious relative to the standard PNF and attention-matched control conditions, and equitable for historically marginalized groups, this R34 project is anticipated to propel a line of research that could yield paradigm-enhancing discoveries pertaining to norms-based alcohol interventions.